Kisspeptin Physiology in Human Reproduction

DESCRIPTION (provided by applicant): The purpose of this grant is to seek financial support for mentoring activities in patient -oriented research to allow young trainees to experience the excitement of scientific discovery. By mentoring, this applicant hopes to build the next generation of clinician investigators by having them experience the wonderful rewards of taking new biologic and health knowledge they have discovered and translating that knowledge into tangible benefits for patients, such as better diagnostic strategies or novel clinical therapies. In order to support such training efforts, this grant would provide financial resources for the applicant, so that she could maintain her own research program while freeing up time for mentoring activities. These mentoring activities involve teaching trainees how to build hypotheses, design protocols, achieve the highest standards of patient safety, address regulatory issues, develop manuscripts, write grants, and meet their career goals. The trainees will work within the applicant's research program in reproductive genetics and physiology. The applicant discovered that mutations in the kisspeptin-GPR54 signaling pathway result in an absence of pubertal development and hypogonadotropic hypogonadism across mammalian species. She is now using kisspeptin administration as the first direct probe of GnRH neuronal integrity in human reproductive biology. Study protocols will include healthy volunteers and patients with congenital GnRH deficiencies who have already been extensively phenotyped and genotyped. Kisspeptin (or analogous compounds) may provide another avenue for therapeutic intervention for patients with reproductive cancers, endometriosis, infertility, and abnormalities of pubertal timing. Patients with reproductive cancers may derive additional benefits given the metastasis suppressor properties of this pathway. Taken together, these projects and the applicant's mentoring will provide a strong program for training new clinical investigators in patient-oriented research. PUBLIC HEALTH RELEVANCE: This grant will support the mentoring activities of the applicant in reproductive physiology so that she can train beginning clinical investigators to have passion for patient oriented research and to develop the skills to build their own investigative programs.

Public health relevance
This grant will support the mentoring activities of the applicant in reproductive physiology so that she can train beginning clinical investigators to have passion for patient oriented research and to develop the skills to build their own investigative programs.